Neural Circuits Underlying Multisensory Control of Orientation in Drosophila

Project Summary!
How the brain combines sensory stimuli from diﬀerent modalities to guide behavior is currently
not understood at a single-cell level. Here we propose to use the model organism Drosophila
to investigate the neural circuit basis of multi-sensory integration in the context of two speciﬁc
orientation behaviors developed in our lab. In one paradigm, odor switches the orientation of
walking ﬂies to a wind (mechanosensory) cue: ﬂies orient downwind in the absence of odor and
upwind in the presence of an attractive odor. In the second paradigm, an aversive wind
stimulus and attractive visual stimulus sum to guide orientation of a tethered ﬂying ﬂy. We have
discovered a novel mechanosensory pathway that computes wind direction from movements
of the ﬂy's antennae, and transmits this information to the central complex, a region of the
brain implicated in navigation. Combined with information from the literature and preliminary
data from our own lab, this suggests a model for how diﬀerent sensory streams might be
aligned and integrated within the central complex. We propose to use optogenetic activation,
chemogenetic silencing, whole-cell electrophysiology, and functional imaging to test the role of
candidate central complex neurons in multi-sensory control of orientation. We will additionally
test the alternative hypothesis that multi-sensory integration in descending neurons is required
for the two behaviors. This study will provide a comprehensive cellular-level account of how
sensory streams are combined to control the orientation of a model organism.!

Public health relevance
Project Narrative Moving through the world requires us to combine information from our eyes, ears, and nose. Where and how such information is integrated to guide movement is poorly understood. Here we will use the fruit ﬂy to understand how multiple stimuli combine to guide behavior.